Integration of Bio-, Medical, and Imaging Informatics for Complex Diseases

DESCRIPTION (provided by applicant): I am a National Library of Medicine (NLM) Biomedical Informatics (BMI) fellow at both the Regenstrief Institute and the Center for Neuroimaging at Indiana University School of Medicine (IUSM). My career goal is to become a successful independent investigator with a focus on integrating bio-, medical, and imaging informatics approaches, including next generation sequencing (NGS) and advanced neuroimaging, to enhance the understanding of complex disease mechanisms and thereby facilitate development of novel treatments. The NLM BMI training program has been a priceless experience that enabled me to successfully transition my career from computational physics to biomedical informatics. During my three year NLM BMI fellowship, I gained extensive experience in advanced medical imaging analysis, medical informatics, bioinformatics, genomics, and statistics to prepare me to achieve my career goal. In order to consolidate my transdisciplinary skills and complete the transition to an independent researcher, my immediate career objective is to apply and expand my methodological skills and gain a broader understanding of current biological knowledge and future computational challenges in BMI. Using whole- exome sequencing pilot project data from the ongoing Alzheimer's Disease Neuroimaging Initiative (ADNI) as an initial learning platform, I will employ bio-, medical, and imaging informatics strategies in an integrated manner to identify functional rare variants associated with intermediate multi-modality phenotypes related to progression from mild cognitive impairment (MCI) to Alzheimer's disease (AD). Prior studies have identified a large number of common genetic variants but a substantial proportion of the heritability of AD remains unexplained by the known susceptibility genes. NGS can help close the gap by rare variant detection. The proposed research plan builds on my previous work in genome-wide association studies (GWAS) using imaging and medical informatics phenotypes and will expand my expertise to NGS. The rich ADNI data set provides a unique opportunity to address the challenges proposed in my specific aims and the IU Center for Neuroimaging serves as the ADNI Genetics Core which greatly facilitates data access and expert assistance. Specific aims: (1) identify a subset of intermediate phenotypic biomarkers associated with a diagnosis of MCI/AD for genetic association analysis in the full ADNI sample set; (2) perform gene set- based association analysis of rare variants with MCI/AD-related intermediate phenotypic biomarkers in the ADNI whole-exome sequencing pilot project; and (3) validate novel variants and risk genes by imputing and genotyping target regions of detected genes in the full ADNI sample set. RELEVANCE TO PUBLIC HEALTH: AD is an increasingly common neurodegenerative disease and the sixth leading cause of death in the United States. Identifying new susceptibility loci with functional impact on MCI progression will enhance mechanistic knowledge regarding AD pathways and may enable earlier diagnosis and treatment.

Public health relevance
NARRATIVE Integrating bio-, medical, and imaging informatics provides a comprehensive and systematic approach to studying the genetic etiology of complex disease, where next generation sequencing data are integratively analyzed with multidimensional imaging and clinical phenotypes and high throughput genotyping data for detection of common and rare variants. Of particular importance is to identify new putative functional rare variants responsible for susceptibility to complex disease. Whole-exome sequencing using next generation technologies, coupled with advanced imaging data and comprehensive medical records, is an effective approach to efficiently detect rare disease-causing variants.